Core E: Outreach, Recruitment and Engagement Core

Inability to efficiently recruit sufficient numbers of participants in observational studies and clinical trials
slows progress in understanding Alzheimer’s disease (AD) and developing effective treatments. This
problem is particularly acute in historically underrepresented groups leading to a lack of diversity and
inclusiveness in research that may mask disease heterogeneity (both clinical and neuropathological), limit
generalizability of results, and inhibit the development of treatments that are effective, safe, and available
for all people.
The goals of the Shiley-Marcos Alzheimer’s Disease Research Center (ADRC) Outreach, Recruitment
and Engagement (ORE) Core are to meet the recruitment needs of the ADRC and affiliated studies through
broad community outreach that provides education about AD and related disorders (ADRD) and presents
opportunities for participation in research, with a particular focus on the large, underserved Latino
population in our region. The ORE Core also strives to maintain engagement with those participating in
ADRD research to maximize retention. To achieve these goals, the ORE Core will 1) develop and
implement sustainable strategies for recruitment of research participants and study partners, ensuring
participation from underrepresented groups and those with reduced healthcare access; 2) provide outreach
to educate community members, community organizations, and local healthcare professionals about ADRD,
the importance of ADRD research, and resources provided by the ADRC; 3) implement methods to engage
current and potential ADRC participants (e.g., identify factors that might increase acceptability of ADRD
research procedures such as autopsy), and to engage students at all levels of education to support the next
generation of individuals working in neuroscience-related careers, and 4) track the success of recruitment,
outreach and engagement activities using defined metrics and recruitment science procedures to assess
the relative value of various strategies. Methods will build upon our prior success in recruiting and retaining
diverse participants in the ADRC longitudinal study and volunteer registry through community-based
memory screening, partnerships with neurology clinics (including those with a large underrepresented
patient base), lay and professional educational activities, quality-of-life programs (e.g., support groups), and
timely dissemination of information on ADRD research, treatment advances and ADRC resources via our
website, newsletters, and social media. With input from key community partners, these efforts will occur in a
manner that is culturally sensitive and appropriate for individuals from diverse groups who may have low
literacy or English as a second language.